Maintain conformance with current Manufactured Food Regulatory Programs Standards (MFRPS) and support a successful North Carolina Food Protection Task Force

Project Summary – Overall
The Manufactured Food Regulatory Programs Standards (MFRPS) enables an
integrated food safety system (IFSS) between federal, state, local and tribal agencies to
share best practices and resources, and establish communication between partners.
Maintaining conformance with the MFRPS, thereby participating in the IFSS is critical to
protect public health and reduce or eliminate foodborne illness. The North Carolina
Department of Agriculture & Consumer Services, Food & Drug Protection Division
proposes methods for maintaining MFRPS conformance and enhancing the IFSS
through maintenance and innovation of our regulatory framework and data sharing
capabilities.
The North Carolina Department of Agriculture & Consumer Services, Food & Drug
Protection Division proposes strategies for maintaining a successful North Carolina
Food Protection Task Force through the creation of collaboration opportunities,
emergency planning and outreach. Support of the Task Force will also protect public
health and reduce foodborne illness while engaging participation of North Carolina-
based stakeholders.

Public health relevance
Project Narrative – Overall The NCDA&CS Food and Drug Protection Division Food Program is submitting the enclosed proposal for funding to continue their efforts towards building the nationally integrated food safety system and maintaining conformance with the Manufactured Food Regulatory Program Standards (MFRPS). The outcomes that will be realized are the improvement of established Program infrastructure, development of new regulatory management practices and increased engagement in the North Carolina Food Protection Task Force. Successful implementation of these outcomes is critical to protect the public against foodborne illness.